YEAST PHEROMONE SIGNAL TRANSDUCTION

DESCRIPTION (provided by applicant): Cell function and behavior depends on the ability to respond to signals in the extracellular environment. In eukaryotic cells, response to external signals is commonly initiated at the plasma membrane and subsequently disseminated throughout the cell by signal transduction pathways, which control cytoplasmic and nuclear events including gene expression. Because of this transfer of information between different compartments, the subcellular localization of signaling proteins is an important aspect of their function. In addition, cellular decisions about whether it is appropriate to respond to a given signal must also be integrated with other information about the physiological status of the cell. This proposal uses the mating reaction of the yeast Saccharomyces cerevisiae as a model system for understanding eukaryotic signal transduction, using a molecular genetics and cell biological approach. Response to mating pheromones in yeast involves the dynamic assembly of plasma membrane-localized signaling complexes, which include proteins found ubiquitously in a variety of signaling systems from yeast to humans, such as a PAK-family kinase, a heterotrimeric G protein, a MAP kinase cascade, and a scaffold protein. The long-term objective of this project is to gain a molecular understanding of how signaling through this pathway is initiated and propagated, with an emphasis on the function of scaffold proteins, the role of subcellular localization, and the interface between signaling and the cell cycle. One goal will be to determine how distinct domains in the MAP kinase cascade scaffold protein, Ste5, regulate the transmission of signal between different pathway kinases, and how different domains interact and coordinate with each other in order to control localization and function. Another project will probe how signaling proteins become restricted to discrete regions at the plasma membrane, and how this impacts the efficiency and dynamics of signal transmission. Also under investigation will be the mechanism by which proteins in this signaling pathway are recognized by specific forms of the cyclin-Cdk kinase during entry into the cell cycle. Overall, these studies will contribute to our general understanding of signal transduction, with relevance to the mechanisms by which both normal and diseased cells make decisions regarding differentiation or proliferation.

Public health relevance
This proposal seeks to shed light on the fundamental mechanisms by which cells respond to external signals. We use a yeast signaling pathway as a model system, but the molecules involved are common to signaling throughout eukaryotic biology, from yeast to humans. The discoveries learned about the basic functions of signaling proteins and pathways under study here will further our understanding of similar signaling events relevant to human health, such as those in vision, hormone responses, and neoplastic growth.